Improving HIV care continuum outcomes among formerly incarcerated individuals through critical time legal interventions

Project Summary. Formerly incarcerated individuals are impacted by health-harming legal needs and risks,
including lack of access to HIV care, unsafe housing safety, unstable employment, and other issues that often
disrupt HIV care. Providing access to legal services can address barriers to HIV care and improve HIV care
continuum outcomes for formerly incarcerated individuals. The proposed study, led by the University of Central
Florida (Hispanic Serving Institution), together with the University of Miami, and Hope and Help Inc., aims to pilot
test a comprehensive critical-time intervention medical legal partnership (CTI-MLP) approach to optimize timely
HIV linkage, retention and viral suppression among formerly incarcerated individuals. MLPs have been used by
social justice-oriented medical, health, social, and legal service practices to identify and address health-harming
legal needs and risks that create barriers to treatment, care, and recovery for several health conditions. MLPs
offer an integrated structural intervention that could improve HIV care continuum and psychosocial outcomes
among formerly incarcerated individuals. Our CTI-MLP intervention package consists of: 1) training for all MLP
staff (clinical, social and behavioral services, and legal) on HIV continuum of care, health-harming legal needs
and risks impacting formerly incarcerated individuals, and MLP structure and operations to ensure that an
integrated and collaborative environment is established from the earliest stages of the program; 2) training for
case managers and court advocate on the legal continuum of care; 3) embedding of legal expertise within
regularized case management team meetings; 4) co-locating legal services in health care agencies through MLP
inter-organizational partnership; and 5) tailoring and implementing organizational best-practices in
communication and information-sharing protocols among providers within MLP, anchored in patient autonomy
and choice. In year 1, we will engage a local community advisory board, scientific advisory board, and legal
expert panel to finalize protocols and the Medical Legal Partnership Training Manual. In year 2, we will implement
the training and pilot test a CTI-MLP initiative with formerly incarcerated individuals living with HIV (n=100). Over
a 6-month period, the team will collect (1) patients' health and functioning, including overall physical health,
mental health, social health, pain, fatigue, and overall perceived quality of life; (2) data on legal needs and risk
factors; (3) patient HIV care clinical outcomes; and (4) clinic-level indicators, including provider-patient
communication and readiness for continued implementation and sustainability. The study will be guided by
Reach, Effectiveness, Adoption, Implementation, and Maintenance and Consolidated Framework for
Implementation Research frameworks. Active engagement will ensure the effective translation and
dissemination of our findings into practice. Completion this project will result in an innovative, evidence-based,
community driven structural intervention to improve HIV care continuum outcomes among formerly incarcerated
individuals.

Public health relevance
Project Narrative The proposed study is highly significant because it addresses the critical health-harming legal needs and risks formerly incarcerated individuals living with HIV and affected by intersecting epidemics. Testing a critical-time intervention medical-legal partnership (CTI-MLP) approach in a community-based setting, as the one proposed in this study, could improve outcomes in the HIV care continuum and patient-reported overall global health by mitigating health harming legal needs and risks and addressing social and structural barriers to HIV care for medically underserved communities. Completion of this project will result in the development of an innovative, evidence-based intervention package to improve HIV care continuum outcomes, prevent and reduce health inequities, improve patient and community health outcomes, and advance health equity among formerly incarcerated individuals living with HIV.